Investigating interference-control in ADHD using a novel forced-response method

PROJECT SUMMARY
Attention deficit/hyperactivity disorder (ADHD) is often considered to be a disorder in children and
adolescents, but is, in fact, diagnosed in 2.5% of adults as well. A main behavioral correlate of ADHD is the
claimed increase in susceptibility to interference from irrelevant external sources. A prevailing view in the
literature is that deficits in executive functions, especially control over interference, underlie ADHD symptoms
(e.g., Barkley, 1997; Pennington & Ozonoff, 1996). Interference control is the ability to prevent interference due
to resource or stimulus competition (Nigg, 2000). However, despite 20 years of research, empirical evidence
for impaired interference control in ADHD patients remains inconclusive using model tasks such as the Simon
task and the flanker task. This may be related to methodological issues that are present in such tasks that are
typically used to assess interference control. The current application is based on a new approach to study
interference control that can avoid these issues. The approach makes use of a “forced-response” method in
which individuals’ responses in conflict tasks are required at a fixed time. This fixed time occurs at a variable
time after the presentation of the imperative stimulus to which individuals must make a response, making it
possible to capture responses at various points in the processing stream. The application includes experiments
using this new approach, and it offers a computational framework to understand how interference control in
ADHD individuals may be compromised compared to healthy individuals.

Public health relevance
PROJECT NARRATIVE (Public Health Relevance) Attention Deficit Hyperactivity Disorder (ADHD) is a condition that affects tens of millions of adults and is often associated with increased susceptibility to interference by irrelevant external stimulation which can adversely affect home and work life. In this project, we propose to (1) use a new method to study susceptibility to interference from irrelevant external information, (2) model the results from this method to uncover the underlying processing difficulties faced by those with ADHD, and (3) apply this method to three different tasks both of which feature the need to control interference.